Patient provider communication and disparities in access to home dialysis and kidney transplantation

PROJECT ABSTRACT
Black and Hispanic patients are less than half as likely to be preemptively waitlisted or receive preemptive
kidney transplantation compared to their non-Hispanic White (NHW) or Asian counterparts. Black and
Hispanic patients are also less than half as likely to receive peritoneal or home hemodialysis compared to their
non-Hispanic White (NHW) or Asian counterparts. To date, a few trials have tested interventions aimed at
reducing the known racial and ethnic inequities in access to preferred kidney replacement therapy (KRT)
modalities such as kidney transplantation and home dialysis, but these interventions have had minimal impact
and even when efficacious, are often difficult to adopt in real-world practice due to the resource investment
needed and the absence of insurer support for these interventions (e.g., patient navigation or home education).
In addition, prior studies have focused primarily on patient-related barriers to accessing home dialysis and
preemptive waitlisting or kidney transplantation. Less attention has been paid to provider-related factors that
may be contributory, such as how and which providers discuss kidney replacement therapy (KRT) options with
patients, and when such discussions begin. The lack of granular data collection on how provider interactions
with patients may mediate racial or ethnic disparities in access to preferred KRT modalities represents a
significant and critical gap in the literature and likely stems from the fact that such granular data are not
typically available in large national registries. Our objective is to leverage unstructured data in provider
documentation embedded within electronic health record systems to understand how provider communication
about KRT options may vary across different racial and ethnic groups (Aim 1), and whether such variations in
patient-provider communication about KRT associates with or mediates the differential access of patients to
preemptive waitlisting, transplantation, or home dialysis (Aim 2). To accomplish Aims 1-2, we will use
harmonized data from diverse healthcare systems that have been centralized at UCSF to complete our
analyses. To complement the data available within provider documentation, in Aim 3, we propose to
innovatively review transcripts of clinic encounters focused on discussions of KRT options. We will apply
qualitative inductive analyses and review these transcripts to identify factors and themes in patient-provider
communication that may vary by patient race/ethnicity. We will then compare these themes to quantitative
data on patient knowledge about KRT, satisfaction with the KRT education they received, and preferences as it
relates to KRT after their clinic encounter. If successful, our study will identify best practices in patient-
provider communication about KRT options that are amenable to simple interventions that could address the
known long-standing inequities in access of racial and ethnic minorities to preferred KRT modalities.

Public health relevance
PROJECT NARRATIVE Racial and ethnic disparities in access to preemptive waitlisting/kidney transplant and home dialysis have been well-described. The objective of this study is to understand the mediators of these disparities, with a focus on patient-provider communication factors that can be intervened upon to improve access of disadvantaged individuals to home dialysis and kidney transplantation.